Resource Core

ABSTRACT - RESOURCE CORE
The American Joint Replacement Registry (AJRR) is part of the American Academy of Orthopedic Surgeons
(AAOS) Registry Program and is the Resource Core of the American Joint Replacement Research-
Collaborative (AJRR-C). The AJRR currently includes >1,200 participating institutions and captures about 25-
30% of all hip and knee TJA procedures in the United States. The AJRR enhances the clinical research
capabilities of the TJA research community by providing access to nationwide shared data resources and
implementing novel data collection, data analysis methodologies and study designs to facilitate TJA research
in large-linked databases and clinical research networks.
The Specific Aims of the Resource Core are: (1) To work collaboratively with the AJRR-C Methodology Core in
design, protocol development, statistical analysis and conduct of TJA studies, (2) To test the transportability
and external validity of TJA-specific validation and artificial intelligence (AI) algorithms (developed by the
Methodology Core) in hospitals within the AJRR network in an effort to improve the depth and completeness of
the registry data, and (3) To participate in pilot & feasibility studies within the AJRR-C network and to develop
analytical standards for use of AJRR data in partnership with academic and community-based institutions. We
will focus on high-priority areas such as risk adjustment when comparing implants and classes of implants, and
use state-of-the-art and novel statistical methods to evaluate new TJA technologies. The availability of implant-
specific data from the AJRR, enriched with linked databases and EHR data sources offer tremendous research
opportunities and will exert a sustained, powerful influence on TJA clinical research landscape and device
surveillance.

Public health relevance
NARRATIVE The Mayo Clinic American Joint Replacement Research-Collaborative (AJRR-C) provides access to nationwide data resources and a network of institutions to facilitate innovative, methodologically rigorous and interdisciplinary clinical research in TJA. AJRR-C addresses the clinical research needs of the TJA research community through training of the next generation of TJA researchers, providing customized consultations, facilitated access to high quality, rich data sources and national TJA registry data as well as infrastructure and methodology support.